Mechanisms for chromatin modification during transcription elongation

DESCRIPTION (provided by applicant): The structure of chromatin is tightly regulated by the well choreographed actions of multiple elements. Disruption of the normal pattern of chromatin often leads to mis-regulation of gene expression, a common feature of cancer and other human diseases. Therefore, it is important to understand the detailed mechanism regulating chromatin dynamics. The long-term objective of this proposal is to understand how chromatin- related complexes help the transcription machinery overcome the nucleosomal barriers while still maintaining genome integrity. Recently, we and others discovered a novel signaling pathway through which RNA polymerase II (Pol II) maintains chromatin integrity while transcribing through nucleosomal templates. A histone methyltransferase Set2 binds the phosphorylated CTD of elongating Pol II and co-transcriptionally methylates histone H3K36, which is then recognized by a histone deacetylase complex, Rpd3S. Once targeted, Rpd3S deacetylates transcribed regions to preserve the accuracy of transcription initiation, thus restricting transcription to bonafide promoters but not cryptic transcription start sites. This proposal is intended to dissect the detailed mechanisms driving this crucial pathway via three specific aims. (1) Analysis of Rpd3S binding to K36 methylated nucleosomes and its implication in transcription elongation. We will test how multiple domains within Rpd3S coordinate to achieve synergistic binding. (2) Dissecting the molecular mechanism by which Pol II exploits K36 methylation as a marker for short term transcription memory. We will examine if elongating Pol II can control the directionality of relevant histone modifications around the transcription fork. (3) Identification of the temporal control mechanism of K36 methylation during transcription elongation. We will explore the roles of histone demethylases and the signals for removal of this reversible histone modification. Importantly, human Set2 has been shown to interact with Huntingtin, the Huntington disease protein; and the treatment of histone deacetylase inhibitors can arrest neurodegeneration in a model system. Therefore, our understanding on the Set2- Rpd3S pathway may also help design potential therapeutic agents to treat neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The results from these studies are expected to advance our understanding of histone code recognition. Many diseases such as cancer and neurodegeneration have been linked to defects in histone modification or the targeting of proteins to modified histones. Thus, our work will provide important potential targets for drugs that treat a variety of human diseases. Project Narrative: The results from these studies are expected to advance our understanding of histone code recognition. Many diseases such as cancer and neurodegeneration have been linked to defects in histone modification or the targeting of proteins to modified histones. Thus, our work will provide important potential targets for drugs that treat a variety of human diseases. __SpecificAimsTextDelimiter__ 2. Specific Aims: Defects in controlling chromatin dynamics are tightly associated with mis-regulation of gene expression patterns, which is a leading cause of cancer and many other human diseases. Our understanding of chromatin regulation has been advanced immensely by the identification of a large number of chromatin regulating enzymes and histone modifications. However, how cells switch on-and-off these histone modifications in a timely fashion during multiple rounds of transcription remains largely unknown. The long term goal of our research program is to understand the molecular mechanism by which chromatin-related complexes help the transcription machinery overcome the nucleosomal barriers while still maintaining genome integrity. The objectives of this application are to determine the critical roles of a landmark histone modification, methylation of lysine 36 of histone H3 (H3K36me), in preserving the stability of chromatin following transcriptional elongation. Our central hypothesis is that H3K36me is a necessary mark for coordinating short-term transcription memory. As a postdoctoral fellow, I co-discovered a novel signaling system whereby the Set2 histone methyltransferase, which is associated with elongating RNA polymerase II (Pol IIo), deposits the H3K36me mark. This mark then signals the Rpd3S complex to deacetylate nucleosomes at coding regions. This pathway ensures that transcription initiation is restricted to bona fide promoters but not at cryptic initiation sites. Here, we propose to dissect detailed mechanism of this crucial transcription elongation pathway by addressing the following Specific Aims: 1. Examination of Rpd3S targeting to K36 methylated chromatin and its implication in transcription elongation We have demonstrated that Rpd3S complex recognizes specific nucleosomes through the combined actions of the chromodomain of Eaf3 (CHD), and the PHD domain of Rco1 (PHD). The CHD is known to bind to K36 methylated histone tails. Here we will identify the nucleosomal target(s) of the PHD, and elucidate how these two domains cooperate to achieve synergistic binding and control the substrate specificity of the complex. We will also determine if the physical presence of Rpd3S alters the accessibility of nucleosomal DNA and if its presence affects transcription elongation in a methylation-dependent manner. 2. Dissecting the molecular mechanism by which Pol II exploits K36 methylation as a marker for short- term transcriptional memory We hypothesize that Pol II directs Set2 to preferentially methylate nucleosomes behind the elongating Pol II. We will test this hypothesis by (1) recapitulating the nucleosomal targeting of Set2 by Pol IIo in vitro; (2) testing whether this targeting directs local methylation using an established in vitro transcription system and a novel approach; (3) determining the functional consequence of K36 methylation on nucleosomal stability, chromatin remodeling and histone eviction. 3. Identification of the temporal control mechanism of K36 methylation during transcription elongation Since the primary function of H3K36me is to recruit Rpd3S, we hypothesize that demethylation of H3K36 occurs after Rpd3S-mediated deacetylation to avoid premature removal of K36me. We will test this hypothesis by exploring the functions of two histone K36 demethylases and their responses to different signals using biochemical, genetic and genomics/proteomics approaches. Upon the completion of this project, we expect to have (1) elucidated how two domains coordinately anchor a complex to modified nucleosomes (This is significant because it provides a blueprint for future screening of multi-valent chromatin recognition, which is considered to be a widespread phenomenon.); (2) a better understanding of the directionality of histone modifications around transcription forks, which is important because DNA replication and recombination machinery likely utilize a similar mechanism; and (3) identified the mechanism for temporal control of removal/deposition of reversible histone modifications. Importantly, since the homology of histone modifications and the corresponding modification complexes across species is remarkably high, we expect that the general principles discovered here will be applicable to higher eukaryotes. ________________________________________________________________________________________ [Note to reviewers on symbols and abbreviations: (HAT), histone acetyltransferase; (HDAC), histone deacetylase; (HMT), histone methyltransferase; (HDMT), histone demethylase; (AcH4), acetylated histone H4; (MLA), methyl-lysine analog; (TAP), tandem affinity purification; (EMSA), electrophoretic mobility-shift assay; (Pol II), RNA polymerase II; (CTD), the c-terminal domain of the largest subunit of RNA polymerase II; (GTF), general transcription factors; (CHD), the chromo domain of Eaf3; (PHD), the PHD domain of Rco1.]